Cytoprotective and Pro-regenerative Neuropeptide as Countermeasure to Mustard Gas Ocular Damage

PROJECT SUMMARY / ABSTRACT
Mustard agents, in particular sulfur mustard and nitrogen mustard, can pose potent threats to both Service
Members and civilians by penetrating exposed tissues and resulting in devastating effects on myriad organs,
among which the ocular surface is the most vulnerable. Around 40% of exposed victims who survive attacks
of mustard suffer from ocular problems, with severe corneal sequelae termed mustard gas keratopathy (MGK)
that impairs corneal transparency and visual function.
The current post-exposure management is very limited and largely ineffective in preventing the
development of MGK. We have recently established a mouse model of nitrogen mustard gas ocular damage
and show significant loss of corneal nerves as reported in human patients, indicating that impaired
neurotrophic support contributes to development of MGK. Among various nerve-derived factors, alpha-
melanocyte-stimulating hormone (α-MSH) is critical to ocular homeostasis through exerting anti-inflammatory,
cytoprotective, and pro-regenerative function. Our pilot study has demonstrated the effectiveness of α-MSH
treatment in preventing the development of persistent corneal epitheliopathy, edema, and opacity, as well as
reducing corneal nerve and endothelial loss, in mice exposed to nitrogen mustard. Mechanistically, we
demonstrate predominant expression of melanocortin receptor-1 (MC1R), among various α-MSH receptors,
in corneal epithelium, suggesting a link of therapeutic effects of topical α-MSH to MC1R signaling pathway.
In the current proposal, we thus hypothesize that topical α-MSH treatment mitigates mustard gas corneal
damage by primarily activating MC1R-mediated protein kinase A (PKA) pathway at the ocular surface that
leads to reduced apoptosis, enhanced regeneration, and suppressed inflammation. The principal objectives
of this project are to (i) assess the therapeutic efficacy of α-MSH in preventing the development of MGK; and
(ii) determine mechanisms by which α-MSH prevents MGK. To achieve these objectives, two specific aims
have been developed: Aim 1: We will test our hypothesis that topical treatment with α-MSH after mustard
exposure prevents persistent corneal epitheliopathy and endothelial damage, reduces nerve degeneration,
and suppresses corneal inflammation and scarring; and Aim 2: We will test our hypothesis that topically
applied α-MSH binds to MC1R in the cornea and activates the PKA pathway to exert its therapeutic function.
Successful completion of this project will help validate a potential molecule capable of mitigating mustard-
induced ocular damage, and thus lay a foundation for our next steps, involving translational studies to further
investigate the function of α-MSH in mitigating sulfur mustard-induced ocular damage.

Public health relevance
PROJECT NARRATIVE Mustard gas keratopathy (MGK) is a sight-threatening, potentially blinding, chronic corneal disease after mustard exposure. Cardinal signs of MGK include persistent corneal epithelial lesions, nerve degeneration, and stromal scarring, which lack definitive treatment despite numerous studies in both humans and animal models. This project, grounded on an established murine model of MGK in our lab, proposes to evaluate the efficacy of a cytoprotective and pro-regenerative neuropeptide, alpha-melanocyte stimulating hormone (α- MSH), as a medical countermeasure against mustard gas ocular damage, and further determine the therapeutic mechanisms.